Immunoengineering of donor lungs to optimize long-term graft function

Project Summary
Lung transplantation is the only treatment option for patients with end-stage lung disease. However, transplant
outcomes are significantly limited by the development of primary graft dysfunction (PGD), chronic lung allograft
dysfunction (CLAD), and complete organ rejection. With increasing lung transplant activity around the world,
new advancements are urgently needed to improve patient survival and quality of life.
At University Health Network (UHN), our team pioneered the Toronto Ex Vivo Lung Perfusion (EVLP)
System—a breakthrough technology whereby donor lungs are preserved in a functional physiological state at
37°C and provided oxygen, nutrients, and other critical resources prior to transplantation. This enables donor
lungs to “breathe” outside of the body for up to 12 hours. Using EVLP, transplant teams can more objectively
assess marginal donor lungs and apply novel repair therapies.
To this end, our project will leverage EVLP to develop novel somatic cell gene editing (SCGE) therapeutic
strategies that can be applied to further enhance donor lungs. In preliminary research, we have shown that: 1)
upregulation of an anti-inflammatory cytokine called interleukin (IL)-10 improves lung quality and post-
transplant outcomes; and 2) recipient regulatory T cells (Tregs) that are resistant to tacrolimus (Tac) improve
the regulatory microenvironment in the transplanted organ. Our hypothesis is that applying SCGE techniques
during EVLP will enhance IL-10 gene and Treg cell therapies, which will immunomodulate the donor organ and
lessen the risk of transplant rejection.
In Aim 1, we will engineer new CRISPR editing technologies for use during EVLP and assess the feasibility
and therapeutic potential of this approach using pre-clinical in vivo models. In Aim 2, we will confer Tac
resistance in Treg cells using base editing and assess Treg efficacy in vivo using a human skin xenograft
model. In Aim 3, we will conduct proof-of-concept translational studies and assess the efficacy of our combined
therapies using clinically declined human lungs on EVLP, representing the closest approximation prior to
clinical application.
In our continued leadership of the field, we will enhance our strategic collaboration with Massachusetts
General Hospital to explore this multidisciplinary approach to long-term transplant tolerance. Our project goal
to combine SCGE and EVLP strategies will enable a grander pursuit of our long-term ambition: to ‘design’
better lungs that will last a lifetime in the transplant recipient. Achievement of our proposed objectives will
result in novel clinical applications and a paradigm shift in how we treat lung transplant recipients—away from
a life of immunosuppressive medications and towards self-sustaining and long-term graft tolerance.

Public health relevance
Project Narrative Lung transplant recipients have low survival rates because their immune system rejects the donor lung. Our project will use new CRISPR genome editing technologies to modify the genetic composition of donor lungs and make them better tolerated in transplant patients. Our studies will enable transplant recipients to live healthy and fulfilling lives without the need for lifelong medication or the fear of organ rejection.